IGF::OT::IGF - University of Vermont to provide support services for the NHLBI Urine Sodium Substudy - Transfer of Samples for a period of performance of one (1) year.

Support services for transfer of samples from the NHLBI Urine Sodium Substudy.